Tailored Non-Pharmacotherapy Services for Chronic Pain: Testing Scalable and Pragmatic Approaches - Admin Supplement

SUMMARY
High impact chronic pain is persistent and limits life and work activities for one in ten adults. Evidence-based
cognitive behavioral therapy for chronic pain (CBT-CP) is widely accepted, effective, and does not rely on
drugs such as opioids. Most professionals trained in CBT-CP are in urban areas, creating a need for these
services in medically underserved and rural areas. Our three-arm comparative effectiveness trial will rigorously
evaluate two low-cost, scalable ways to deliver CBT-CP: (1) an 8-session, one-on-one, professionally
delivered telephonic/video CBT-CP program, and 2) a previously developed and tested 8-session on-line CBT-
CP based program (painTRAINER). Comparison will be to usual care augmented with a guide to chronic pain
management by the American Chronic Pain Association. Our long-term objective is increasing CBT-CP
availability, especially for communities affected by the opioid crisis. This study aims to determine the
effectiveness of the telephonic CBT-CP and online program on improving patients’ pain severity (primary
outcome) as well as their impact on additional outcomes including quality of life, depression, sleep and long-
term opioid use. We will examine patient and system factors that reduce pain severity and the role of theory-
based mediators such as catastrophizing and self-efficacy; as well as conduct qualitative evaluations to
understand, describe, and explain barriers and facilitators to intervention adoption, implementation and
sustainability. The cost and incremental cost-effectiveness of the telephonic CBT-CP and online program will
also be assessed compared to each other and usual care. Our population is adults with high impact chronic
pain who receive care in one of four diverse healthcare systems. Eligible, consenting participants will be
randomized to one of the three study arms. Self-reported pain severity and secondary outcomes will be
assessed at baseline and at 3, 6, and 12 months. Regression models for longitudinal data allowing
interactions between assessment time and randomization arm will be used to estimate intervention effects at 3
months, the primary endpoint. This project addresses national priorities including identifying effective, low-
cost, low-risk care models for pain management, especially behavioral treatments for self-management that
can be readily implemented and disseminated. If effective, these remotely delivered CBT-CP programs have
the potential to spread nationally, similar to phone interventions for tobacco cessation and weight loss, to
reduce the personal and economic burdens of chronic pain.

Public health relevance
NARRATIVE One in ten U.S. adults has high-impact chronic pain that limits life and work activities. Cognitive-behavioral therapy for chronic pain is an effective treatment that could be used instead of drug treatments such as opioids. We will determine the effectiveness, costs, and important factors for providing this therapy online and by phone—two telehealth methods that could make it more available to people in underserved and rural areas.